Community Engagement Core

Community Engagement Core Project Summary
The values and principles underlying community-engaged research have led to its prominence as an essential
strategy for conducting health disparities research, particularly in the realm of cardiometabolic conditions. By
centering the equitable engagement of all collaborating partners during each stage of the research process,
community-engaged research holds promise for supporting the cultural relevance, translation, and
dissemination of promising interventions that disrupt the relationships between socially patterned structural
factors, and the consequent emergence of health inequities. However, it is not enough to merely consult with
or involve stakeholders in the research enterprise. To fully realize the power of community-engaged research,
stakeholder partners must be positioned and acknowledged as leaders, co-creators, and co-developers. This
requires intentional efforts to amplify stakeholders' influence throughout every phase of the research process
through shared leadership and ownership.
The Community Engagement Core (CEC) of the proposed Mid-Atlantic Center for Cardiometabolic Health
Equity (MACCHE), jointly led by Dr. Lisa A. Cooper, Reverend Debra Hickman, and Dr. Chidinma A. Ibe,
will serve as the MACCHE's focal point for cultivating, organizing, and promoting bi-directional learning and
communication between consortium partners and a robust cadre of multisectoral stakeholders. To accomplish
this goal, we will employ best-practices in community-based participatory research to ensure that the voices
and perspectives of marginalized communities are embedded into the fabric of MACCHE's research and
training initiatives. Specifically, we will 1) construct and implement a shared governance structure that places
stakeholders as leaders within the Center and its studies; 2) advance, facilitate, and evaluate MACCHE's
community-engaged research efforts, and 3) co-design strategies to translate, disseminate, and sustain
MACCHE initiatives. Taken together, these efforts will cultivate an environment of collaboration that amplifies
the lived experiences and expertise of our partners to facilitate the translation, dissemination, adoption, and
sustainability of our interventions and key research findings. This has implications for the success of our
research and for advancing health equity in the Mid-Atlantic region.